Significance of Protein Synthesis by the Integrated Stress Response in Neuromodulatory Neurons for Adaptive Behavior and Synaptic Plasticity

ABSTRACT
Plasticity mechanisms endow the brain with immense capacity to adapt to a wide range of experience and
exposures. Protein synthesis, including locally at synapses, is a requirement for many forms of synaptic
plasticity. The Integrated Stress Response, ISR, is a highly conserved biochemical pathway that regulates
protein synthesis. The ISR markedly shifts which proteins are made by phosphorylating the initiation factor,
eIF2alpha. The ISR was named for its effects body-wide - in which it provides a cell stress response
mechanism. However, in the brain, the ISR has also been found to be a potent modifier of synaptic plasticity,
learning and memory. At a high level of summary, ISR inhibition in the normal brain has been shown to lower
the thresholds of experience needed to instantiate long-lasting memory and in some disease settings, such as
traumatic brain injury, it rescues cognitive behavioral deficits. Mechanistically, ISR-inhibiting manipulations
have been associated with long-lasting potentiation (LTP); while ISR activation is necessary for forms of
synaptic depression (LTD).
While trying to understand how the ISR contributes to diseases like dementia and dystonia, we recognized
major gaps in the basic understanding of brain ISR actions, including when and where it was normally
activated. We therefore developed a brain-wide viral reporter, SPOTlight, that gives a two-color readout for ISR
activation state. Using SPOTlight, we uncovered a wholly non-canonical modality for the ISR in the brain –
involving its constitutive activation in a class of neurons (striatal cholinergic interneurons) where it influences
dopaminergic modulation of their firing response. Additionally, cell autonomous ISR inhibition in these cells
recapitulated previous “learning enhancement” effects observed with systemic manipulations. These findings
either upend, or at least substantially add to, working models for the ISR in plasticity, learning and memory.
Here, we propose to advance understanding of how the ISR acts in the brain for neuromodulation, synaptic
plasticity, learning and memory. We will focus on 3 knowledge gaps: (1) To what extent does ISR action in
neuromodulatory cells, instead of at local synapses undergoing plasticity, explain ISR effects on synaptic
plasticity and behavior? (2) What are the molecular mechanisms by which the ISR changes dopamine (D2R)
signal transduction outcomes in cholinergic neurons? and (3) Can new ISR reporters be developed with the
spatiotemporal resolution needed to resolve when and where the ISR activates protein synthesis under
synaptic plasticity conditions? We expect the outcomes of this work to impact both general cell biological
principles and specific striatal mechanisms and to have translational relevance for ISR-targeting therapeutic
efforts that are underway.

Public health relevance
PROJECT NARRATIVE The proposed studies aim to reveal new molecular and cellular mechanisms for learning, memory and synaptic plasticity involving the role of a specific biochemical pathway controlling protein synthesis and the process of cholinergic neuromodulation. The knowledge gained may uncover new molecular targets to consider for therapy development for a wide range of human disorders, including aging and memory-related conditions. Mechanisms revealed specifically in the basal ganglia circuitry may further provide insights helpful for a range of conditions that include Parkinson's disease, dystonia, Tourette's syndrome, addiction, Obsessive compulsive disorder and autism.